Acquisition of Fusion Lumos Orbitrap mass spectrometer

Project Summary Advances in powerful research technologies such as mass spectrometry have enabled researchers to not only catalogue the many variants of the protein complement of an organism or organelle system, but more recently, using quantitative proteomic tools, to specifically quantitate each protein component both spatially and temporally within the cell. The acquisition of the ThermoFisher Fusion Lumos Orbitrap mass spectrometer (MS) is crucial to the research infrastructure at the Institute for Systems Biology (ISB) and the collaborative partnership with the Center for Infectious Disease Research (CIDR). This instrument will enable the development and broad dissemination of next-generation technology and instrumentation to researchers ranging from Ph.D. students and post-docs, to experienced PI's at ISB and CIDR and other collaborating institutes. Used by experimentalists and computational biologists, the data collected with the proposed instrumentation will enhance the understanding of protein function and action through identification and quantitation of peptides, their posttranslational modifications and will ultimately inform researchers of proteome dynamics that are responsible for an organism's form and functions. The acquisition of the ThermoFisher Fusion Lumos Orbitrap mass spectrometer will substantially improve our ability to carry out large-scale proteomics experiments at unprecedented depths of proteome coverage that includes novel PTM analysis such as phosphorylation, ADP-Ribosylation, carbohydrate analysis, and quantitative proteomics and metabolomics in our research programs. Our request for a Fusion Lumos Orbitrap MS will enable researchers to perform in-depth studies of the protein networks underlying critical cellular processes, such as innate immunity, peroxisome function, cell-cell signaling via secreted vesicles and responses to DNA damage, make inferences from the interacting network of genes and their transcripts important to understanding the biological context of disease progression. The proposed instrument is critical for the success of such experiments because of its unique capabilities, including the ability to screen out chemical background noise, sequence greater numbers of proteotypic and metabolic signatures of target proteins and metabolites per unit time utilizing very high efficiency chromatography and fast MS scanning rates. We will be able to identify post-translational modifications with very high specificity and sensitivity not currently achievable with other mass spectrometers in house or nearby. Currently, ISB and CIDR have access to a previous generation (several generations older) ThermoFisher LTQ-Velos-Pro Orbitrap Elite MS with ISB staff providing expertise in experimental design, data acquisition and interpretation however, our needs far exceed our current capabilities. The planned acquisition and implementation plan described is crucial for the development and completion of research currently underway at each institute and with their respective collaborating partners.

Public health relevance
Project narrative Recent advances in mass spectrometry enable researchers to not only catalogue the many variants of the protein complement of an organism or organelle system, but with appropriate instrumentation and quantitative proteomic analysis tools, researchers can now specifically and comprehensively quantitate the proteome of an organism, both spatially and temporally. These advances help elucidate the molecular mechanisms that give rise to cellular functions and can give context to a particular disease state. Armed with this information, we can use systems biology approaches to understand wellness, aging, attack by infectious agents and ultimately design interventions against protein interactions for therapeutic purposes and the benefit of public health.